MULTICENTER INVESTIGATION OF NONTUBERCULOUS ASPIRATION IN PATIENTS WITH CF

The objective of this investigation is to determine the impact of non-tuberculous mycobacteria on the natural course of cystic fibrosis lung disease in the US.